CORTICAL EXCITABILITY AFTER TRACKING VS NON-TRACKING TASKS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Therapists are responsible for retraining of movement for people with a neurological problem (i.e. stroke). This proposal will question whether this retraining should involve simple tasks or more cognitively involved tasks.